Mechanisms of chromatin and transcriptional regulation

Abstract of Parent Award
Histone post-translational modifications (PTMs), chromatin-remodeling enzymes, DNA
methylation, and histone chaperones play critical roles in the organization and control of
our genomes. Importantly, disruption or mutation of the proteins or enzymes responsible
for chromatin regulation underlies a number of human diseases, most notably cancer. Our
long-term goal is to elucidate the molecular underpinnings of chromatin regulation and
define how this regulation contributes to human biology and disease. Our lab has
spearheaded the pursuit of this goal, making seminal discoveries that explain how the
chromatin-modifying machinery “writes” and “reads” histone PTMs and how histone PTMs
function in transcription, DNA replication, DNA repair, and maintenance of DNA
methylation. Yet, despite considerable progress, there remain many crucial knowledge
gaps. For example, it is largely unknown the extent to which histone PTMs function in a
combinatorial manner. Similarly, we do not fully understand the biochemical basis for
recognition of histone PTMs by the many different reader domains in chromatin-
associated proteins nor do we fully understand how paired reader domains bind
nucleosomes in a multivalent manner. Finally, we do not know the functions of newly
identified histone PTMs, e.g., lysine crotonylation. With this MIRA award, our lab will close
these knowledge gaps by answering three of the foremost fundamental questions in
chromatin biology: 1) How do histone-modifying enzymes and chaperones regulate
transcription, the cell cycle, and maintain chromatin integrity? 2) How do recently
discovered histone PTMs such as crotonylation contribute to gene regulation? 3) To what
extent do histone PTMs collaborate to regulate downstream functions in chromatin?

Public health relevance
PROJECT NARRATIVE Defects in chromatin organization, gene transcription, and DNA packaging are major causes of human disease, notably cancer. Our studies will uncover the functions of readers and writers of histone post-translational modifications and histone variants, as well as the function of a histone chaperone complex. These studies will advance our fundamental understanding of the chromatin regulators that are dysregulated in human disease, thereby identifying new targets for therapeutic intervention.